Consortium Led Evaluation of Integrated Human-Relevant Approaches to Identify Drug Induced Cardiovascular Liabilities

Title: Consortium Led Evaluation of Integrated Human-Relevant Approaches to Identify Drug
Induced Cardiovascular Liabilities
FOA Title and Number: Validating Human Stem Cell Cardiomyocyte Technology for Better
Predictive Assessment of Drug-Induced Cardiac Toxicity (U01 Clinical Trial Not Allowed), RFA-
FD-19-002
Proposed project start date: September 30, 2019
Proposed end date: September 30, 2022
Project Summary/Abstract:
Cardiovascular drug-induced toxicity remains a major cause of drug attrition in both preclinical
and clinical phases of drug development (Laverty et al., 2011). This is likely due to gaps in the
traditional preclinical models used to assess cardiotoxicities. Additionally, many of the traditional
methods are deployed in later stages of drug development causing costly late stage attrition.
Advancements in both in vitro technology platforms and human stem cell-derived
cardiomyocytes (hSC-CMs) offer an opportunity to improve the current preclinical testing
paradigm by using mechanistically-relevant assays earlier in the drug development process. A
paradigm shift like this will require appropriate confidence in the assay platforms, cells and
underlying mechanisms associated with the cardiotoxicities, as well as gathering expertise to
conduct evaluation and validation, a complex task.
These efforts are best suited to a collaborative effort between multiple stakeholders including
individual scientists and organizations. This proposal includes an effort to first define cellular
mechanisms of cardiovascular toxicity, followed by a process to test and build confidence in the
in vitro methods capable of predicting said toxicities. The objective of this proposed research
aligns well with the FDA’s area of interest, “1. Modernize Toxicology to Enhance Product
Safety.”
Skilled scientific coordination and management is a requirement for the efficient design and
execution of multi-site collaborative science. This is particularly essential for the studies
proposed here that are intended to provide direct value to applied drug development and drug
safety via engagement of public and private sector scientists. This multi-sector and multi-
disciplinary expertise will allow the proposed program to effectively define core cardiovascular
liabilities and build consensus on the utility of novel in vitro assays that provide insights into
these liabilities. The organizational experience, in addition to a broad scientific membership,
gives HESI the credibility needed to conduct unbiased science and give the drug development
community confidence in these new assays. HESI is the right organization to tackle these
challenges and address the cardiovascular safety issues from a novel and twenty-first century
science perspective.

Public health relevance
Title: Consortium Led Evaluation of Integrated Human-Relevant Approaches to Identify Drug Induced Cardiovascular Liabilities FOA Title and Number: Validating Human Stem Cell Cardiomyocyte Technology for Better Predictive Assessment of Drug-Induced Cardiac Toxicity (U01 Clinical Trial Not Allowed), RFA- FD-19-002 Proposed project start date: September 30, 2019 Proposed end date: September 30, 2022 Project Narrative: The Health and Environmental Sciences Institute (HESI) proposes to advance and modernize drug development through a better understanding of underlying mechanisms of cardiotoxicity. These underlying mechanisms can be evaluated using novel assay platforms using human- based stem cells, a change from the current paradigm of animal models that do not always translate to human outcomes. Coordinated by HESI, multiple partners will be identified to conduct a series of studies to evaluate and build confidence in the novel systems.